Empowering Women and Providers for Improved Care of Urinary Incontinence: EMPOWER Study

Urinary incontinence is a chronic and serious condition with a high rate of incidence that is associated with
poor sleep quality, depression, social isolation, and neurological or cognitive problems. Urinary incontinence is
common among women, effecting over 25% of all adult women globally, but it is often underdiagnosed.
Researchers suspect that urinary incontinence prevalence rates are difficult to capture due to cultural
perceptions of urinary incontinence, methodological differences, survey items that yield differential responses
due to wording, differences in case definitions and having access to validated measures. While the
consequences of urinary incontinence (UI) are not fatal, the burden on individuals with UI is significant and has
a profound effect on quality of life. Research has concluded that while there are many effective interventions
for urinary incontinence, methods to diagnose and treat urinary incontinence lack sensitivity to adequately
identify all who suffer with this condition. We seek to increase awareness of this problem. Moreover, because
racial disparities in the diagnosis and treatment of chronic medical conditions are common, it is suspected that
there may also be a diagnosis and treatment disparity for urinary incontinence among African American (AA)
women. There is a gap in the existing literature and we do not know if AA women are diagnosed and treated
less frequently for urinary incontinence compared to other women. Our goal is to understand the diagnosis and
management of urinary incontinence in African American women, both from the standpoint of incidence and
treatment rates, and from the standpoint of the illness experience of affected women. In this study, we will
develop, apply and refine a search criteria to identify urinary incontinence in AA women from EHR data. We
will utilize this criteria to evaluate and identify any racial disparities in the diagnosis of urinary incontinence in
AA women and racial disparities in the treatment rates and types of treatment provided. We will also interview
African American women who are affected by urinary incontinence and who participated in the AHRQ funded
“Empowering Women and Providers for Improved Care of Urinary Incontinence: EMPOWER Study”. Focused
interviews will characterize the experience of illness, diagnosis and treatment of the problem. We will code the
data to identify themes in the responses and interpret these themes with EHR data findings to provide
empirically informed guidance and a deeper understanding of addressing UI in African American women.

Public health relevance
Urinary incontinence, common among adult women, is a chronic and serious condition with a high rate of incidence that is associated with poor sleep quality, depression, social isolation, and neurological or cognitive problems. This study will investigate if there is a racial disparity for African American women in the diagnosis and treatment of urinary incontinence. Using EHR data and focused interviews, we will gain a better understanding of the prevalence and treatment of the condition in AA women. Study findings will provide empirically informed guidance to address UI in African American women.